Clinical Core

PROJECT SUMMARY
The objective of our Cooperative Center for Human Immunology (CCHI) is to use the analysis of
vaccine induced immunity and natural infections to Influenza and Sars COV-2 as a model for defining
adaptive and innate immune mechanisms and antiviral protection in adults. The Clinical Core will be
responsible for coordinating protocol design and implementation to maximize opportunities for parallel
evaluations across the research projects and scientific cores, obtaining human subjects approvals,
and creating and managing the centralized database to record clinical data. The Clinical Core will
coordinate distribution of relevant specimens to the HIMC Core and provide matched de-identified
clinical data for analysis. As the work proceeds, the Clinical Core database will facilitate comparative
analyses of results obtained from the individual research projects. One of the goals of the Clinical
Core is to make the necessary IRB submissions for clinical studies, recruit and enroll adults into the
protocols, assure that participant rights are respected throughout the duration of their trial participation
and provide follow-up to assure collection of complete sets of data from all subjects. Participant
reimbursement payments will be provided by the core. We will provide centralized clinical data
management for research projects and other cores using an electronic database with electronic data
entry and implement a quality management plan to assure data integrity. These data will then be made
available to the research projects and scientific cores for final data analysis. Biospecimens (blood)
and clinical data will be collected by the Clinical Core staff according to the specifications of each
clinical study protocol and delivered either to the CTRU laboratory or directly to research project staff.

Public health relevance
We have assembled a broad and highly accomplished team to continue our investigations of Influenza and SARS-CoV-2 vaccination and infection, particular focusing on subjects that are vulnerable and seeking a deeper understanding of the effects of specific antibody glycosylation and specificity, bioinformatic signatures of pan virus responses and human immune organoids and the tissues and organs they interact with.